Data Management for Molecule Simulation : A Throughput-Oriented Approach

Project Summary
We will design and develop a molecular simulation data management system, we call P2DMS, to analyze large dis-
tributed molecular dynamics (MD) simulation data. The salient features of the system include: (1) a push-based local
query engine design that handles data in a batch processing manner and processes many queries at the same time;
(2) optimized MD analytics tools using modern many-core hardware such as GPUs; and (3) efﬁcient management and
access to distributed data over wide area networks, which is quite common for large scale MD simulations. This will
be done by building a data analysis layer on top of state-of-the-art distributed big data management systems. The out-
come of this project will not only improve the efﬁciency of MD data processing, but also enable new knowledge discov-
ery that is currently regarded difﬁcult or infeasible. In particular, we will integrate the P2DMS program into existing MD
simulation packages, and validate the new design with important real-world biological and MD methodological prob-
lems. In particular, we will (1) model the structure-function relationships of how the spike protein of SARS-CoV-2 inter-
acts with the human angiotensin converting enzyme 2 (ACE2) receptor; and (2) enhance the performance of a recently
developed parameter optimization software for active control of MD simulations.

Public health relevance
Project Narrative We propose a novel MD data analysis framework that can signiﬁcantly improve throughput and latency of data analysis tasks. It will also beneﬁt computer simulations as a high throughput means for researchers to study the structure, dynamics, and thermodynamics of biomolecules. This will greatly impact many ﬁelds of medical research such as discovery of new medicines, biomimetic material design, and pathology/diagnosis of genetic diseases.